PHYSICAL ACTIVITY ENHANCEMENT FOR CHILDREN AND PARENTS

DESCRIPTION: This application proposes the development of an interactive, video-based program targeted to children who do not engage in enough physical activity and their families. The program will help children learn how to be physically active, teach them basic behavioral skills needed to develop and maintain a physically active lifestyle and actively involve parents in the process. The program will be delivered by primary care pediatricians and will capitalize on their authority to motivate patient behavioral change. The combination of these elements represents a true innovation in physical activity promotion and primary care prevention of illnesses related to sedentary behavior. During Phase I, a prototype program will be developed to demonstrate the nature and quality of the materials, consisting of a rapid, self-administered screening measure for use by physicians, and videotape, parent guidebook and child- parent workbook materials for home use by families. The prototype will be tested with families and physicians for user satisfaction. Phase II will include a randomized clinical field trial of the programs efficacy. If effective in improving levels of child physical activity and teaches parents to support their children in this manner, it would represent a significant advance in child health promotion. PROPOSED COMMERCIAL APPLICATION: NOT AVAILABLE